CLINICAL AND HORMONAL EFFECTS OF GROWTH HORMONE RELEASING PEPTIDE-30 DAY

This is a study to investigate the safety and efficacy of GHRP-2 (Growth Hormone Releasing Peptide) administered subcutaneously to healthy young adults for 30 days. The study wishes to determine if growth hormone release can be stimulated and if chronic administration of GHRP-2 alters the acute GH response to GHRP-2.